Impact of the Therapeutic Alliance on Reduction of Disparities in Latino End-of-Life Cancer Care

PROJECT SUMMARY
This proposal aims to develop and pilot test a theoretically-grounded, behavioral intervention to promote the
development of a therapeutic alliance between oncologists and Latino advanced cancer patients. This
intervention will be grounded in the theoretical model of the TA and a conceptual model of the TA in Latino
cancer patients that we will develop through the proposed formative research. Based on data from the
literature and our preliminary studies, this intervention will seek to improve oncologist TA by promoting trust,
empathy, shared decision-making, and patient-centered communication. The intervention framework will be
based on Self Determination Theory (SDT), which posits that behaviour change (improvement in TA) is more
likely when conditions of autonomy, competence, and relatedness are met. First, mixed methods will be used
to create a conceptual model of the TA between oncologists and Latino cancer patients to determine targets
for the intervention (Fig 1). Aim1a will leverage data from an ongoing funded multi-site, prospective
observational R01 on medical/religious/cultural beliefs, TA, and EOL care outcomes (n>270). For Aim 1b, we
will conduct in-depth interviews and focus groups with oncologists (n=9) and Latino cancer patients (n=35) in
order to gain a more nuanced understanding of the TA and refine our conceptual model. Once the intervention
has been created, we will then refine the intervention using stakeholder (Aim 1b participants) feedback
regarding its feasibility and acceptability. For Aim 3, an independent set of 8 oncologists and 50 patients will be
studied, half (n=4 oncologists, 25 patients) will be randomized to training in the TA intervention, and the other
half (n=4, 25) will be randomized in to usual care. We will examine feasibility (rate of intervention completion),
acceptability (oncologists’ and patients’ satisfaction), and efficacy of the TA intervention for improving the TA
between oncologists and Latino cancer patients, as measured by patient THC scores as the primary outcome.
Secondary outcomes will include engagement in ACP and EOL care. Dr. Tergas’s long-term career goal is to
establish a leading, independent program of research focused on the reduction of disparities in EOL care by
implementing and disseminating effective, empirically-supported interventions for use in clinical practice. As a
foundation for her independent research program, her short-term career goal is to develop an implementable,
evidence-based behavioral intervention for improving therapeutic alliance between oncologists and Latino
cancer patients. This K08 award application represents the cornerstone of her strategy to achieve my short-
term goal and consists of cohesive and complementary research aims and training objectives. Specifically, in
order to achieve her career goals, she needs training in intervention development and implementation science,
as well as continued training and mentorship in EOL care disparities. Conducting the research detailed in my
research aims will help me achieve this training and experience, as well as provide preliminary data for a future
R01-level grant application.

Public health relevance
PROJECT NARRATIVE Cancer is the leading cause of death among Latinos in the US, who now represent the largest minority group. Latino cancer patients engage in advance care planning less often and receive less value-consistent care at the end-of-life more often than non-Latino cancer patients. The proposed research addresses the pressing need to reduce Latino EoL care disparities by developing an intervention for improving the therapeutic alliance between oncologists and their Latino cancer patients.